A Rapid, Sensitive and Instrument-free Oral Fluid Fentanyl Test

Project Summary
Fentanyl is a major contributor to the Opioid Epidemic, causing increasing morbidity and
mortality. Rapid identification of fentanyl in different body fluid samples enables prompt and
appropriate administration of naloxone, and the appropriate level of clinical care. The clinical and
public health urgency for the wide availability of rapid fentanyl tests is recognized in the clinical
and scientific field. We have successfully developed a rapid fentanyl urine test, which was
designated as an FDA Breakthrough Device in 2023 and is pending FDA 510(k) clearance for
over-the-counter (OTC) use. Compared to urine, oral fluid is easy to obtain from overdosed
individuals at home or in the emergency transportation vehicles for rapid fentanyl identification. In
the drug compliance or workplace drug testing settings, oral fluid collection has the advantage of
being directly observable and tamper resistant. Although there is good correlation between urine
and oral fluid fentanyl concentrations, fentanyl concentration in oral fluid is significantly lower.
Towards the goal of developing a highly sensitive oral fluid fentanyl rapid test, Instanosis was
awarded a NIDA Phase I SBIR grant and Supplement to develop a high affinity anti-fentanyl
antibody and oral fluid fentanyl test prototype. Having successfully completed Phase I and
Supplement, in this Phase II project, we propose to further integrate prototype components and
finalize the oral fluid fentanyl test design and conduct verification and validation studies to prepare
for FDA submission. The goal is to develop the first FDA-cleared oral fluid fentanyl rapid test that
has a diagnostic cutoff at <1 ng/mL fentanyl (>10x more sensitive than commercially available
forensic test cup), readout time 5 min (4x less time than commercially available forensic test cup),
and required oral fluid 100 µL (10x less volume than commercially available forensic test cup).

Public health relevance
Project Narrative We propose to develop and commercialize the first regulatory approved over-the-counter test for rapid, sensitive and instrument-free oral fluid fentanyl detection. The resources developed in this proposal will allow us to quickly modify the technology for other analytes and respond rapidly to emerging drug threats.